Functions of IKK alpha in Skin Homeostasis and Skin Tumorigenesis

It is yet unknown how the interaction of fungus, tumors, and immune cells affects tumorigenesis. We uncovered that the enhanced STAT3-dependent oral squamous cell carcinoma (SCC) development by oral Cladosporium cladosporioides infection promoted the fungal growth whereas infection was cleaned up in wild-type mice, suggesting a synergic tumor-fungus loop involved in this accelerated carcinogenesis. Oral acidic metabolites elicited by C. cladosporioides infection were found to convert protective neutrophils to inflammatory neutrophils characterized by elevated IL-1b and decreased ROS, that failed to kill fungi. Such a neutrophil population expressing IL1B associated with fungi was identified in human head and neck SCCs (HNSCCs). Importantly, fungal counts were much greater in HNSCCs and SCC-adjacent tissues than in healthy controls, and the advanced HNSCCs had significantly increased fungal signals. A Firmicutes to Protobacteria change and enhanced bacterial numbers, which were also mediated by a C. cladosporioides-dependent oral acidic tumor milieu in mice, were detected in HNSCC patients showing poor survival. C. cladosporioides and induced IL-1b/IL-17A augmented STAT3 activity in SCC cells, contributing to local and distal skin tumorigenesis. Collectively, these traits shared between fungus-associated HNSCCs in humans and mice highlight that oral fungal infection constitutes the tumor microenvironment for tumor progression.